Transitional Care for Skilled Nursing Facility Patients with Alzheimer’s Disease and Related Dementias and their Caregivers: a Cluster Randomized Trial.

Every year 400,000 people with Alzheimer’s disease and related dementias (ADRD) are hospitalized, transfer to a skilled nursing facility (SNF), and transition to home, assisted living, or long term care. After discharge, one in five patients are re-hospitalized within 30 days, and their caregivers experience high levels of strain and psychological harm. To promote effective transitions from SNF to home and other destinations, we designed the Connect-Home ADRD transitional care intervention (C-H ADRD), an adaptation of Connect-Home transitional care. Our recent trial of Connect-Home generated evidence for intervention efficacy in a population of 327 patient and caregiver dyads. In a supplemental award, we identified unique needs of SNF patients with ADRD and their caregivers. We designed the C-H ADRD intervention to address those needs: (1) before discharge, SNF staff develop an ADRD transition plan with patient and caregiver dyads and (2) after discharge, a Dementia Caregiving Specialist provides phone-based support for the ADRD transition plan. In a pilot study, we demonstrated C-H ADRD’s feasibility, acceptability, and potential to reduce caregiver strain and patient neuropsychiatric symptoms (NPS). The next logical step is an efficacy test of C-H ADRD. Our Objective is to conduct a parallel arms, cluster randomized trial (CRT) of C-H ADRD, enrolling 360 ADRD patient and caregiver dyads in 12 SNFs. The Specific Aims are:
Aim 1: Conduct an efficacy CRT of C-H ADRD (intervention) vs. usual discharge planning (control) and compare caregiver outcomes 30 days after discharge: (1) caregiver strain (primary) and (2) depression and preparedness for care transitions (secondary).
Aim 2: Compare patient outcomes between intervention and control arms 30 days after discharge: (1) patient NPS (primary) and (2) quality of life and acute care use (secondary). Exploratory: Examine whether caregiver strain modifies intervention effect on patient outcomes.
Aim 3: Examine potential variability in Connect-Home ADRD outcomes and implementation. (3a) Determine intervention impact by patient discharge destination and other factors for caregiver and patient outcomes. (3b) Identify factors at the dyad-level (e.g., patient discharge destination) and SNF-level (e.g., quality rating) contributing to fidelity to the C-H ADRD protocol.
IMPACT: C-H ADRD has potential to improve health outcomes of people with ADRD and their caregivers.

Public health relevance
Every year, 400,000 million skilled nursing facility (SNF) patients with Alzheimer’s disease and related dementias (ADRD) transfer from SNFs to home and other destinations. Following these transitions, (1) patients with ADRD experience high rates of preventable dementia symptoms and re-hospitalization and (2) caregivers of people with ADRD experience high levels of strain and psychological harm. To improve these outcomes, we propose a cluster randomized trial of Connect-Home ADRD, a transitional care intervention for persons with ADRD and their caregivers during care transitions from SNFs to home, assisted living, and long term care.